UCSF Dermatology Training Grant

Project Summary/Abstract
The Dermatology Department at the University of California, San Francisco, has a long tradition of training
promising young scientists to be successful, independent investigators. The UCSF Dermatology Training
Program encourages physician scientist trainees to pursue cutting edge research in any laboratory at the
university. This allows the trainees to choose from all the outstanding UC faculty, regardless of their
departmental affiliation. With the continued and upcoming space expansion to the Mission Bay and Parnassus
Campuses, UCSF has added a significant amount of research space, has recruited numerous new faculty
members, and will continue to do so to take advantage of the new space being made available. The UCSF
Dermatology Department has also expanded over the last 5 years in terms of research space and the number
of faculty conducting basic and translational research. Building on our successes in the past, we propose to
continue to support four postdoctoral trainees per year who are either physician-scientists or Ph.D. scientists.
New changes to the training program include adopting additional methods for independent program evaluation,
adding new training faculty as mentors, and developing a more detailed plan to enhance diversity, equity, and
inclusion. Ultimately, we hope to support trainees for a lifetime of scholarly pursuits with the goal of
understanding the molecular and social determinants of skin diseases, identifying new therapies for these
diseases, and ensuring that scientific discoveries lead to advances in public health in an equitable and cost-
effective manner.

Public health relevance
Project Narrative The UCSF Dermatology Training Program encourages physician scientist trainees to pursue cutting edge research and prepares them for a lifetime of scholarly pursuits with the ultimate goal of understanding the molecular and social determinants of skin diseases, identifying new therapies for these diseases, and ensuring that scientific discoveries lead to advances in public health in an equitable and cost-effective manner.